RCT to Evaluate an Implementation Strategy to Increase Optimal Use of HPV Vaccine in Primary Care

Project Summary
Primary prevention of HPV-related urogenital and oropharyngeal cancers could significantly reduce
morbidity, mortality, and healthcare costs associated with these commonly occurring cancers. The vaccine
targeting oncogenic strains of the human papilloma virus (HPV) can prevent HPV-related cancers if given to
girls and boys before exposure to these sexually transmitted viruses. Yet, in the United States (U.S.), more
than 10 years after introduction of the vaccine, fewer than half of the target population is vaccinated.
The objective of this application is to evaluate the effectiveness of an implementation strategy (the
intervention) to improve optimal use of the HPV vaccine. Optimal use requires completion of the 2-dose series
before sexual debut. To this end, national recommendations from the Centers for Disease Control and
Prevention (CDC) are to complete the 2-dose HPV vaccine series by age 13. The theory-based, multi-
component intervention was developed in collaboration with primary care providers and includes: 1) an
educational video to increase the provider’s knowledge about guideline recommendations and patient and
practice benefits of vaccination by age 13; 2) audit and feedback of vaccine coverage to increase motivation to
engage in practice change; 3) a communication strategy to improve the provider’s communication skills and
their self-efficacy to address parental hesitation; and 4) practice facilitation to support practice change to
develop a sustainable HPV vaccine delivery system. The intervention will be delivered through a series of brief
practice visits with the facilitator that occur every 1-4 weeks over 2 years. In a pilot study, the intervention was
well-accepted and resulted in a clinically meaningful improvement in vaccine initiation of 19 percentage points
over 15-months.
This promising intervention will be evaluated in a cluster-randomized trial in 20 primary care pediatric
practices in Missouri, a state with low HPV vaccine coverage. Study objectives are to 1) determine if the
intervention will increase initiation (primary outcome) and completion (secondary outcome) of the 2-dose HPV
vaccine series for preteens before their 13th birthday; 2) determine if provider motivation and improved
communication skills mediate the effectiveness of the intervention; and 3) assess factors important for scaling
including fidelity, acceptance by primary care providers and parents, and cost. Vaccine use in preteens will be
assessed at baseline, at 24 months to assess effectiveness, and at 36 months to assess if change is
sustained. For the primary analyses, aggregates of patient-level data will be used to estimate provider
behavior, extracting data from the practices’ electronic medical record.

Public health relevance
Project Narrative The ultimate goal of the proposal is to provide critical new knowledge in how to change care delivery in the primary care setting to ensure optimal use of the human papilloma virus (HPV) vaccine and to inform implementation of future cancer-preventing vaccines targeting children. Primary prevention of HPV-related urogenital and oropharyngeal cancers could significantly reduce morbidity, mortality, and healthcare costs associated with these commonly occurring cancers.